Antifungal discovery from previously uncultivated bacteria

ABSTRACT
Candida auris is a multidrug-resistant yeast that can cause invasive infection and death. It spreads easily
between hospitalized patients and nursing home residents. C. auris is especially hazardous to
immunosuppressed patients and those hospitalized with Covid‐19. Particularly concerning, some strains of C.
auris are resistant to all three major classes of antifungal drugs. As a result, this deadly pathogen has been
classified as an Urgent Threat by the Centers for Disease Control (CDC), and new antifungal drugs are
desperately needed.
Most antifungal drugs are derived from natural compounds produced by environmental microorganisms.
However, screening for antifungals from this source has fallen into disfavor, as the readily culturable
microorganisms have been overmined. However, 99% of environmental microorganisms have never been
screened because they will not grow under normal laboratory conditions. To address this problem, we used our
iChip culturing technology to assemble a large collection of previously uncultured microorganisms. The iChip
enables microorganisms to grow in their natural environment (e.g., soils), giving them access to essential growth
factors. As a result, we screen microorganisms that are inaccessible to other drug discovery programs. We have
used the iChip technology to discover several new antibacterial compounds such as teixobactin, which is
currently in IND-enabling studies to treat drug-resistant bacterial infections. In this project we will screen our
unique microbe collection for compounds that kill C. auris.
In preliminary studies, we screened a small number of our iChip isolates (3,000) against C. auris. From this
limited screening, we have already found five potentially novel antifungals, which we will pursue in this project.
In addition, we will screen a much larger number of our isolates (30,000) to obtain additional promising
compounds. Crude extracts will first be produced from fermentations and screened against C. auris. The
compounds producing the antifungal activity will then be isolated from the extracts to determine their chemical
novelty, potency against other important fungi (including drug-resistant strains), cytotoxicity, and frequency of
resistance. Promising compounds will then be tested in a mouse efficacy model of fungal infection (disseminated
candidiasis). Compounds that show good animal efficacy will be considered lead compounds and their full
chemical structure will be elucidated. Our goal at the end of this project is to discover 1-2 novel lead compounds
for preclinical development to combat C. auris and potentially other fungal infections.

Public health relevance
NARRATIVE The fungal pathogen Candida auris is a major public health concern, particularly in healthcare facilities and nursing homes. The focus of this project is to screen our unique microbial culture collection for new drugs to combat C. auris.